PHASE I STUDY OF CGP 48664 IN CANCER PATIENTS

Patients with histologically or cytologically confirmed solid tumors (including lymphomas) which are refractory to conventional therapy or for which no standard therapy exists will be recruited for this phase I trial of CGP 48664. The study will establish safety and tolerability of the agent, a maximum tolerated dose after one cycle of treatment, and data on the pharmacokinetics of CGP 48664.